Nosocomial pneumonias impair cognitive function

PROJECT SUMMARY OF THE FUNDED PARENT GRANT AWARD
Patients in intensive care units are at high risk for long-term health threats including cognitive impairment. The
correlation was only recently revealed after large-scale follow-up cognitive assessments on intensive patient
survivors after their discharge from the hospital. There are testimonials, reviews and calls-to-action on many
critical care websites and in journal issues over the last 2-3 years on this public health crisis. However, the
causative mechanisms that lead to abrupt cognitive impairment are unclear—they are not attributable to age,
gender, relative brain hypoxia, anesthetics and sedatives.
Nosocomial bacteria such as Pseudomonas aeruginosa impair endothelial cell function during the course of
infection that culminates in acute lung injury. Recent studies implicate that after P. aeruginosa infection,
endothelial cells produce and releases cytotoxic amyloids that are transmissible among cells. Having access to
the endothelium of whole blood circulation, these cytotoxic amyloids likely propagate. In fact, the amyloids are
detectable in the blood and cerebrospinal fluid of nosocomial pneumonia patients in intensive care units. Further,
when applied to brain slices, the cytotoxic amyloids derived from endothelium impair neural activity and synaptic
information transfer.
This project takes advantage of vertically integrated approaches, ranging from the use of different bacteria stains
and cultured cells, to in vitro brain slice recordings and in vivo animal behavior studies. The studies are designs
to test the hypothesis that nosocomial pneumonias induce amyloid protein accumulation in CSF, resulting in LTP
suppression and learning deficit. Altogether, studies systematically examine a possible lung-brain axis, where a
primary lung infection induces production of cytotoxic amyloids that spread to the cerebrospinal fluid and
contribute to cognitive impairment. This work addresses a novel mechanism underlying the end organ
dysfunction that is evident during, and in the aftermath of, critical illness. Mechanistic insight into endothelium-
derived cytotoxicity to brain function will reveal novel therapeutic approaches to prevent cognitive decline.
PROJECT SUMMARY OF THE CURRENT ADMINISTRATIVE SUPPLEMENT APPLICATION
Studies outlined in this project are designed to leverage a new humanized amyloid-β mouse. This mouse model
was not available during preparation of the original submission and it will represent an important advance for the
field to integrate this new mouse into our proposed studies.

Public health relevance
PROJECT NARRATIVE Many intensive care unit survivors suffer from pervasive cognitive impairment comparable to patients with early-stage Alzheimer’s disease. While the causative mechanisms that lead to abrupt cognitive impairment are unclear, recent studies show that lung vascular endothelium produces cytotoxins after nosocomial bacterial infection. This application seeks to examine the effects of lung infection and sepsis using a novel, humanized amyloid-β mouse model to increase the translational relevance of studies described in the parent award.